Regulation of NF-kappaB in Lung Epithelium by ROS/RNS

DESCRIPTION (provided by applicant): Oxidants are widely regarded as molecules that contribute to chronic lung inflammation, and a direct role for oxidants in the activation of the transcription factor, Nuclear Factor kappa B, has been suggested. Perhaps surprisingly, during previous funding cycles of this grant, we have demonstrated that S-glutathionylation, a reversible cysteine oxidation, constitutes an active negative feed-back mechanism to shut down NF-κB activation. S-glutathionylation of Inhibitory kappa B kinase beta (IKKβ), the most proximal kinase in the canonical NF-κB activation pathway, is critical in inhibiting its catalytic activity. S-glutathionylation of IKKβ (IKKβ-SSG) occurs in epithelial cells stimulated with lipopolysaccharide (LPS) or house dust mite, and is important in shutting down the activation of NF-κB. IKKβ-SSG was reversed by glutaredoxin (Grx1), which under physiological conditions specifically catalyses deglutathionylation, thereby restoring the sulfhydryl group of IKKβ, and prolonging NF-κB activation. Mice that systemically lack Grx1 demonstrate accelerated resolution of inflammation and airways hyperresponsiveness (AHR) in response to the antigen, ovalbumin. Conversely, inducible overexpression of Grx1 in bronchiolar epithelium dramatically increases inflammation in response to LPS. These findings point to the importance of the S-glutathionylation/glutaredoxin redox axis as an important module to control the extent and duration of allergic inflammation. Exciting recent findings by our laboratory have illuminated the functional importance of Glutathione S-Transferase pi (GSTP) as a feed forward catalyst of IKKβ-SSG that inhibits the activation of NF-κB, and dampens NF-κB driven pro-inflammatory signaling in lung epithelium. GSTP is known classically for its role in phase II drug metabolism. However, a protective role for GSTP in inflammatory lung diseases has emerged, based upon findings of enhanced ovalbumin-induced inflammation and airways hyperresponsiveness in GSTP knock-out mice compared to WT animals, and studies demonstrating a link between a GSTP polymorphism and atopy and bronchial hyperresponsiveness in patients of asthma. However, to date no functional link between GSTP, S-glutathionylation of NF-κB, and expression of pro-inflammatory mediators in epithelial cells has been established. The hypothesis of this proposal is that GSTP and Grx1 act in a balance to control S-glutathionylation of NF-κB. Furthermore, we hypothesize that GSTP-catalyzed S-glutathionylation of the IKK signalsome constitutes an active anti- inflammatory mechanism that dampens allergic airways disease. In Specific Aim #1 we will determine the functional interrelationship between GSTP and Grx1 in controlling NF-κB activation in lung epithelial cells. Specific Aim #2: will address the role of Grx1 and GSTP in airway epithelial cells for the duration of allergic airways disease in mice, and in Specific Aim #3: we seek to unravel the functional determinants of GSTP that govern S-glutathionylation of IKKβ and repression of NF-κB. In this aim we will also express human polymorphic variants of GSTP (Ile/Val 105, Ala/Val 114)) and determine their impact of S-glutathionylation of IKKβ and regulation of pro-inflammatory signaling. Completion of this application will provide new avenues to limit allergic inflammation, and also provide new insights into the anti-inflammatory mechanism of GSTP, which is essentially unknown.

Public health relevance
This project will measure certain chemical events, known as cysteine oxidations in models of asthma. The project will test the hypothesis that increasing these chemical events are important in decreasing inflammation. We will also test certain variants of a human gene, known as glutathione S-transferase P (GSTP) to determine whether these variants differ in their potency to halt inflammation, in order to better understand how gene variations of GSTP relate to asthma. Completion of this project may lead to new strategies to diminish the inflammatory process in patients with asthma.